Molecular Mechanisms Underlying Adaptor-Mediated Integrin Signaling in a Species-Specific Manner

Project Summary
This is a request for an NIGMS Administrative Supplement to NIGMS grant R35GM119560, to purchase a
miniDAWN Multi-Angle Light Scattering (MALS) Detector from Wyatt Technology. Our previous structural and
functional studies of integrin signaling pathway reveal that integrin activity is tightly regulated by a few signaling
adaptor proteins. Formation of protein complexes or protein homo-oligomers mediates the signal transduction
that leads to integrin activation and clustering. With the miniDAWN MALS detector, we can monitor the formation
of these complexes/oligomers by accurately determining the absolute molar masses and sizes of protein
macromolecules in solution. The instrument will provide the necessary capabilities to maximize productivity and
fully achieve the aims of the proposed research project. Institutional matching funds will contribute to the
purchase of this instrument.

Public health relevance
Project Narrative Abnormal expression and hyperactivity of integrins can cause severe diseases including cardiovascular diseases, autoimmune diseases, and increased tumor metastasis. Integrin activation is tightly regulated by signaling adaptor proteins through the assembly of protein complexes or homo-oligomers. Therefore, we request funding to purchase a miniDAWN Multi-Angle Light Scattering (MALS) Detector from Wyatt Technology, which will enable us to monitor the formation of these complexes/oligomers.